ALTERING THE IMMUNE LANDSCAPE TO AUGMENT BONE REGENERATION

PROJECT SUMMARY
The overarching hypothesis of this project is that bone regeneration can be enhanced by exploiting
vaccination status and recruiting adaptive immunity to the injury site through controlled release of an
antigen. To test this hypothesis, the general approach in this project will be to immunize mice and
then perform in vivo bone tissue engineering studies to test the impact of antigen delivery from the
scaffold on bone formation and the immune response. The mice will specifically be vaccinated
against influenza due to high annual vaccine coverage in the U.S. population, and influenza-derived
hemagglutinin (HAG) peptide will be delivered from implanted scaffolds. Testing will be performed in
mice using two experimental models, calvarial defects and femoral defects. In both models, the bone
defects will be treated with hydrogel scaffolds releasing HAG peptide alone or in combination with
therapeutic or sub-therapeutic doses of recombinant human bone morphogenetic protein-2 (BMP-2).
All treatments will be duplicated in an unvaccinated control group using both male and female mice to
test for gender effects. There are two Specific Aims. Aim 1 is focused on evaluating bone formation
and defect regeneration, which will be evaluated at 3 weeks and 6 weeks after treatment by
microcomputed tomography analysis and histology. The results will be benchmarked against defect
treatment with a therapeutic dose of BMP-2 delivered from a collagen sponge, which will serve as a
clinical control treatment. Aim 2 is focused on evaluating the effects of HAG peptide delivery on the
immune response. Immune cell infiltration in the regenerating defects will be evaluated at 3 weeks
and 6 weeks after treatment by immunostaining. In addition, transcriptomic changes will be evaluated
1 week after treatment by single-cell RNA sequencing. If successful, this project will lead to novel
regenerative immunotherapies with high translational potential.

Public health relevance
PROJECT NARRATIVE Cells of the immune system are known to play a critical role in bone healing and regeneration. In this project, we will test if immune memory from vaccination can be exploited to alter the immune response to a bone injury and improve healing and regeneration. If successful, this project will lead to novel regenerative immunotherapies with high translational potential for a variety of injuries and diseases.